Promoting remyelination in multiple sclerosis by simultaneously modulating myelin debris clearance and myelin lipid synthesis

Summary Statement/Abstract
Multiple sclerosis (MS) is the most common demyelinating disease, affecting approximately 400,000 people in the
United States and 2.5 million people worldwide. It is not clear what causes MS, but many believe that it is because
our own immune system attacks oligodendrocytes that generate myelin. However, the current therapies that dampen
our immune system can only relieve the symptoms but not cure the disease itself. Therefore, it is urgent to find novel
therapeutic approaches that can cure the disease, for instance by promoting remyelination. The central nervous
system has great potential to regenerate oligodendrocytes and remyelinate in response to myelin damage, however
the ability of remyelination is greatly diminished in the MS lesions. Two major reasons are known to prevent efficient
remyelination in MS lesions: 1) damaged myelin cannot be efficiently cleared, thereby preventing formation of new
oligodendrocytes, and 2) newly generated and/or existing oligodendrocytes have lost the ability to form new myelin.
We have identified a key regulator – Quaking (protein name: Qki; gene name: Qk) – that is potent to overcome both
obstacles. Firstly, we discovered that Qki is a key regulator of phagocytosis of microglia. Depletion of Qki in microglia
greatly reduced the phagocytic activity of microglia, which is critical for clearance of myelin debris and consequently
remyelination. Secondly, we discovered that Qki is a major regulator of oligodendrocyte differentiation and myelin
homeostasis by regulating lipid metabolism of both newly formed oligodendrocytes and existing oligodendrocytes in
the demyelinating lesions. Mature myelin has been considered an inert material for decades. However, our study
showed that mature myelin is in fact a very dynamic material through exploiting our genetic systems by depleting
Qki in mature myelinating oligodendrocytes of adult mice. The comparative lipidomic and transcriptomic analyses
identified Qki as an essential factor for myelin lipid biosynthesis by controlling the transcription of the lipid metabolism
genes, particularly those for fatty acid desaturation and elongation, via coactivation of the peroxisome proliferator-
activated receptor beta (PPARβ)-retinoid X receptor alpha (RXRα) complex. These findings were corroborated by
functional rescue experiments with brain penetrant PPARβ/RXRα agonists, KD3010 and bexarotene. We
hypothesize that restoring lipid metabolism by activating PPARβ/RXRα/Qki function will help remyelination in MS
through two ways: 1) activating microglia’s function to clear myelin debris, consequently promoting oligodendrocyte
regeneration, and 2) enhancing lipid generation of existing and newly generated oligodendrocytes. To test this
hypothesis, we propose the following three specific aims. To test this hypothesis, we propose the following three
specific aims: 1) To investigate the role of Qki/PPARβ in microglial phagocytosis in clearing myelin debris and
promoting remyelination, 2) to investigate the role of Qki/PPARβ in myelin lipid metabolism and remyelination, and
3) to elucidate the mechanism by which Qki functions as a coactivator to enhance PPARβ transcription activity in
both microglia and oligodendrocytes. Our studies will not only provide insights into the etiological mechanism for
MS, but more importantly, help MS patients find a cure through targeting remyelinating pathway.

Public health relevance
Narrative The current immunomodulatory therapies of multiple sclerosis (MS) can only relieve the symptoms but are ineffective in curing the disease, so it is urgent for the field to find novel therapeutic approaches that can cure the disease, for instance by promoting remyelination. The central nervous system has great potential to regenerate oligodendrocytes and remyelinate in response to myelin damage, however the ability of remyelination is greatly diminished in the MS lesions. Here we aim to test the hypothesis that activating PPARβ/RXRα/Qki function will help remyelination in MS through two ways: 1) activating microglia’s function to clear myelin debris, consequently promoting oligodendrocyte regeneration, and 2) enhancing lipid generation of existing and newly generated oligodendrocytes.